Administrative Core

Project Summary: Administrative Core
The Administrative Core will support an environment of research excellence, scientific innovation, and
transdisciplinary scholarship within the Washington University Participant Engagement and Cancer Genomic
Sequencing (WU-PE-CGS) Center and among other members of the NCI PE-CGS network of research
centers and the coordinating center. The Administrative Core will implement a matrix-style administrative
structure to foster excellence in management and communication. Leaders and co-leaders of the three working
units in the Center will form the Leadership Committee, which (together with patient advocates) will use a
collaborative process to engage and maintain the creativity and leadership of the significant individual and
team expertise involved in the Center. The goal of the Administrative Core is to provide the structure for
effective and efficient operation and maintenance of the WU-PE-CGS center in compliance with NIH and
University guidelines, while leveraging innovative opportunities to advance the field of participant engagement
and cancer genomics. The Core will support the overall mission of the WU-PE-CGS through the following
aims: (1) Organize the operational structure and scientific leadership for all WU-PE-CGS components and
provide oversight to maximize efficiency, effectiveness, and accountability; (2) Build participant engagement for
underserved/understudied populations to engage in network-driven collaborative studies via outreach among
other Centers in the network and collaboration with patient advocacy groups; (3) Provide scientific leadership
in minority and underserved participant engagement and in genome sequencing among other scientists in the
network; (4) Evaluate all WU-PE-CGS activities and provide feedback to refine ongoing activities; (5) Establish
a timeline and milestones to monitor progress and coordinate efforts. The administrative core will position the
WU-PE-CGS to optimize the innovation, pace, and impact of participant engagement research and
genomic characterization of rare, understudied cancers. The WU-PE-CGS investigators have substantial
expertise and proven track records in conducting collaborative, transdisciplinary science, including research
and programs in cancer control, genome sequencing, dissemination of findings to other stakeholders, and
translating results for practitioners working in multiple settings. We are uniquely situated to provide scientific
leadership to connect and expand a network of cancer-focused participant engagement researchers; support
innovation; and enhance capacity for genome sequencing of rare and understudied cancers and directly
interact with patient advocacy groups and patients for return of results and ongoing participant engagement.
The Administrative Core is a critical element of the overall scientific program and infrastructure for the Center
and provides a strong foundation for scholarly excellence, research synergy and efficiency, and clinical and
community impact of the Center during and beyond the five-year initial funding period